Core 4: Statistical Analysis and Data Dissemination

Abstract
The overall function of the Statistical Analysis and Data Dissemination (S2D) is to provide strong support to
data management, data dissemination, study design, statistical analysis and manuscript writing for proposed
research projects in the center for Translational Proteomics in Alzheimer's Disease. High quality data is the
cornerstone for the success of the center for Translational Proteomics in Alzheimer's Disease, since almost all
the center-supported research will be data driven. Therefore, it is extremely important to build efficient data
management systems to house data of various types and analyze them appropriately for both generating
important discoveries as well as guiding the conduction of the proposed research. The core team has rich
experience in conducting Alzheimer's Disease-related research and plan to focus on managing data, providing
high quality statistical support throughout the research and working with laboratory scientists to aide them in
their own analyses of the data.